EFFECTS OF POWER OUPUT &IMAGING TECH ON ULTRASOUND CONTRAST PROD BY ALBUNEX

The purpose of this research is to study how varying the settings on the ultrasound system effects the echocardiogram with Albunex.